Administrative Core

Abstract - Administrative Core
The Administrative Core will facilitate all aspects of the research program assisting in regulatory
compliance and allocation of resources, monitoring recruitment of patients and distribution of
sample aiding in the preparation of reports and manuscripts, and scheduling regular meetings
among investigators and trainees and with the External Advisory Committee.